Identifying the drivers of ESX1 evolution in Mycobacterium tuberculosis

Project Summary
Even in trial settings, 5-10% of patients with uncomplicated, drug sensitive TB fail treatment. Data from our
lab and others suggest that there are bacterial determinants of treatment response, in addition to high level
drug resistance, which contribute to the variability in treatment response]. Population genomic analyses have
defined Mtb genes under positive selection, providing a genetic roadmap to the differences between Mtb
strains that may contribute to treatment failure. These include known drug resistance genes but also a few
canonical virulence genes including multiple components of the ESX1 secretion system. Multiple structural
components of the ESX1 system as well as two key ESX1 regulators show evidence of genetic diversification
and positive selection to a similar degree and following similar timeline as known drug resistance genes. The
cadence of ESX1 mutation suggests that they are driven by a strong selective pressure that began relatively
recently, which we hypothesize to be drug. We will test the model that Mtb strains alter drug responses in
people by altering their ESX1-dependent interactions with the host. We term this concept “virulence
associated drug resistance”. In this R21, we propose two Aims to acquire foundational data to test this model.
In the first Aim, we will use bacterial genetic approaches to ask what are the effects of clinically prevalent
variants on ESX1 function in vitro? And in the second Aim, we will use mouse and macrophage models to test
the effects of clinically prevalent variants on virulence and treatment outcomes in vivo. We anticipate that the
results of these studies will provide data to direct more extensive, mechanistic dissection of ESX1 evolution
in Mtb in future work.

Public health relevance
Project Narrative A few genes in Mycobacterium tuberculosis continue to evolve in clinical strains. Some are expected, like the genes causing canonical antibiotic resistance, but we also find unexpected changes in a key virulence system. We will test the hypothesis that these are a new class of drug resistance mutations.